Maternal-Neonatal Registry (PAIR) Supplemental Funding

PROJECT SUMMARY
The Eunice Kennedy Shriver NICHD Maternal-Fetal Medicine Units (MFMU) Network is a
collaboration between fourteen Clinical Centers, the Data Coordinating Center (DCC) and the
NICHD. Each clinical center is led by a Center Principal Investigator who is experienced in
perinatal research and completion of both observational studies and clinical trials. Each clinical
center also has a full-time Research Coordinator dedicated only to MFMU Network studies.
Robust clinical research infrastructure is maintained to ensure successful participation in all
MFMU studies.
The purpose of the Parent And Infant Registry (PAIR) is to collect linked baseline and outcome
data for high-risk preterm pregnant persons and their infants. These data will be collected in a
uniform manner from medical records of pregnant persons and infants admitted to hospitals
participating in the Eunice Kennedy Shriver National Institute of Child Health and Human
Development (NICHD) Maternal-Fetal Medicine Units Network (MFMU) and Neonatal Research
Network (NRN).
The aims of this project are to:
Aim 1: Obtain screening information on all pregnant people hospitalized during periviable
gestations.
Aim 2: Describe outcomes of pregnant persons who deliver during the periviable window with
linked neonatal outcomes.
Aim 3: Capture data on periviable antepartum stillbirths, which are not currently captured in any
Network registry.
Aim 4: Describe the incidence, timing, and outcomes of periviable antenatal counseling.
The funding providing by this administrative supplement will allow for an extension of the data
collection period, thus increasing the sample size of the pilot cohort.

Public health relevance
PROJECT NARRATIVE Several registries exist across different study networks. Using existing maternal and neonatal registries to identify common data elements with the same definitions will improve collection of information on mothers and babies in future studies.